Mechanisms that alter lymphatic transport in inflammatory bowel disease

ABSTRACT
Reactive lymphangiogenesis requires B cell-expressed lymphotoxin (LT)α. LTα signals through TNFR1 or
TNFR2 when it is presented to cells as a LTα3 homotrimer, or it signals through LTβR when it is part of the
LTa1b2 heterotrimeric complex. Lymphangitis has been described as a feature of Crohn's disease, but the
nature and role of lymphangitis in the disease has not been elucidated. In resected tissue from Crohn's
disease patients, outflow lymphatic trunks (called collecting lymphatic vessels) running from the ileum through
the mesentery and on to draining lymph nodes appeared obstructed by tertiary lymphoid organs (TLOs) that
formed around them. The TLOs were rich in B cells. In a mouse model of ileitis driven by a mutation in the
mRNA locus for the cytokine TNF (TNF∆ARE mice) that increases TNF abundance when the gene is
environmentally triggered, TLOs developed along mesenteric collecting lymphatics draining the ileum, like
patients. The mice display marked blockade of lymph flow due to obstruction by the TLOs, which raised lymph
pressure so that flow did not move forward but pushed backwards through lymphatic collaterals toward the gut.
Backflow characterizes compromised valves. Indeed, TLOs mainly formed where lymphatic valves lost their
identity and quiescence. Instead, these valve sites supported lymphangiogenesis that partially encapsulated
expanding TLOs. Before lymphangiogenesis got underway, B cells accumulated around lymphatic valves.
These B cells may be the source of cytokines that act on the lymphatic vessels. Indeed, data so far suggest
that the action of TNF on lymphatic endothelium may be sufficient in vitro and in vivo to reprogram valve-
associated genes critical to the maintenance of normal lymph flow. That is, early blockade with anti-TNF
neutralizing mAb restores lymph flow and prevents progression of TLOs. At late stages in disease, anti-TNF
therapy becomes less effective as the TLOs have greatly expanded and enlarged, but nonetheless anti-TNF
still partially restores mesenteric lymph flow, suggesting that TNF remains a key, and possibly required, signal
in disease progression. However, it remains unclear if the TLOs per se drive worsened ileitis. What would
happen if the TLOs did not form but other inflammatory pathways were left intact? In preliminary data for this
application, we have identified a means to prevent TLO formation: TLOs do not form in the absence of B cells.
Furthermore, TNF and/or LTα expressed by B cells is required for the formation of TLOs in the ileitis-affected
mesentery of TNFARE mice. These data cause us to hypothesize that TNF receptor ligands TNF and/or LTα
derived from B cells act through TNF receptors on lymphatic endothelium to drive tertiary lymphoid organ
(TLO) formation by skewing signals that normally maintain lymphatic valve integrity. We predict, in turn, that
TLOs govern the pathophysiology of the disease itself by trapping inflammatory cells and mediators rather than
allowing such mediators to disseminate and enhance systemic pathology. This model predicts a Catch-22
feature of TLOs: they protect against some forms of pathology but drive others.

Public health relevance
PROJECT NARRATIVE Crohn's disease has long been associated with the concept of impaired lymphatic drainage. In this application, we reveal that impaired lymph flow is due to formation of tertiary lymphoid organs (TLOs) that obstruct the outflow lymphatic vessels of the gut. In this application, we seek to determine how these TLOs form and whether they exacerbate disease, following up on surprising evidence that they may have a benefit in containing the spread of systemic manifestations of Crohn's disease.